Increasing Kindergarten Social-Emotional Skills for Positive Long-Term Mental Health: A Pilot Test of the Strengthening Social-Emotional Skills for Relating and Thriving at School (SSTRS) Program

ABSTRACT/PROJECT SUMMARY
The ultimate goal of this research is to prevent the development of mental health (MH) problems in youth, and
thus a number of harmful outcomes including suicide, substance abuse, and criminality, by preventing deficits
in children’s social-emotional (SE) skills—which are transdiagnostic risk factors for a range of MH problems—
at the transition to kindergarten (K), one of the earliest points to reach large numbers of young children. The
Social-Emotional Skills for Thriving and Relating at School (SSTRS) Program is specifically designed to
increase SE skills in K through programming tailored to kindergarteners’ learning needs, and an integrated
parent curriculum. The SSTRS Program was designed to address barriers to accessibility and widespread
implementation of the Kids In Transition to School Program—an evidence-based, summer K transition
program—shown to increase the SE skills and distal positive MH outcomes (e.g., reduced suicidality) of
students from socioeconomically disadvantaged backgrounds. The proposed study will allow for a pilot study of
this adaptation to determine its effects on the posited mechanisms of intervention action—children’s SE skills
and parent’s positive discipline skills and involvement in school—and children’s MH outcomes. Using a
simplified dynamic waitlist-controlled, cluster-randomized design, we will collect data at baseline (BL),
immediately post-intervention (P; 2-months post BL) and follow-up (F; 8-months post BL) from 300 incoming
kindergartners enrolled in three schools serving a high proportion of children from socioeconomically
disadvantaged backgrounds and their parents. The Specific Aims include examining: the effects of the SSTRS
Program on children’s SE skills and parents’ involvement in school and positive parenting skills at P, and
children’s MH outcomes at F; the hypothesis that changes in children’s SE skills and parents’ involvement and
parenting skills are mechanisms through which the intervention improves children’s MH outcomes; and the
feasibility and acceptability of SSTRS from parent, educator, and district administrator perspectives to
determine which processes might be particularly helpful in supporting the scale up of SSTRS and which
processes may need further refinement. These activities will allow us to produce finalized curricula as well as
effect size estimates to demonstrate that an R01 would be sufficiently powered to both demonstrate
intervention effectiveness and allow robust examination of facilitators of and barriers to implementation and
scalability at the teacher, school, and district levels.

Public health relevance
PROJECT NARRATIVE The overarching goal of this research is to prevent the development of mental health problems in youth, and thus a number of harmful outcomes including suicide, substance abuse, and criminality. The proposed project will do this by testing an intervention designed to prevent deficits in children’s social-emotional skills—which are known transdiagnostic risk factors for a range of mental health problems—at the transition to kindergarten, one of the earliest points to reach large numbers of young children. By the end of the project, we aim to provide a widely scalable, developmentally-tailored, school-based preventive intervention that will set the youngest students on a path towards positive mental health across childhood, adolescence, and adulthood.